Effects of environmental contaminants on anxiety-like and fear behaviors, and gut-microbiota in rodents

Project Summary
Our goal is to understand the effects of environmental contaminants, namely glyphosate, on
anxiety-like and fear-related behaviors, and determine possible links between gut microbial
imbalances and behavioral deficits. The increased risk of human exposure to chemicals from
food preservatives, agriculture and industrial production suggests a link between exposure to
environmental toxins, such as glyphosate, and the development of neurological and emotional
disorders. Glyphosate, the active ingredient in glyphosate-based herbicides, was initially
considered safe for mammals since it exerts its effect by inhibiting a metabolic route that is not
present in mammals. Glyphosate targets an enzyme only found in plants and microorganisms.
However, gut microbiota benefits the host by acting as a defense against pathogens and
regulating normal brain function. The Gut-Brain axis is a bidirectional communication between
gut microbiota and the nervous system involving neural, endocrine, and inflammatory
mechanisms mediated by microbes. Disturbances along the Gut-Brain-Axis may contribute to
neural pathogenesis by altering microbiota composition and generating a cascade of events
which lead to emotional dysregulation. The influence of glyphosate on anxiety-like and fear-
related behaviors is unclear. The long-term goal of this project is to better understand the
potential relationship between the influence of glyphosate on anxiety, fear and gut microbiota,
by examining potential biological links. Our central hypothesis is that glyphosate can impact
mental health by acting against gut microbes. Understanding how glyphosate impacts rat gut
symbionts, their behavior and brain pathophysiology will help elucidate a possible role of this
chemical to anxiety and fear. We will give either glyphosate-contaminated drinking water or
filtered water to adult male and female rats and perform behavioral studies for anxiety-like and
fear-related behaviors. We hypothesize that prolonged drinking of glyphosate-contaminated
water will lead to increased anxiety-like and fear-related behaviors. In addition, by evaluating
changes in the composition of gastrointestinal microbiota, we will identify microbial imbalances
that may correlate with changes in brain pathophysiology in the development of emotional
disorders. Our two specific aims are as follows: Aim 1: Determine the effects of glyphosate on
anxiety-like behaviors, brain histology, and gut microbiota. Aim 2: Determine the effects of
glyphosate on fear memory, brain histology, and gut microbiota.

Public health relevance
Relevance Consumption of environmental contaminants may affect behaviors related to anxiety and fear, which is relevant to the mission of the Research Domain Criteria (RDoC; NIMH) of NIH, NIEHS and NCCIH. A biological link must be examined using reliable behavioral tests to evaluate a relationship between consumption of contaminants and mental health disorders. Notably, unfortunately, environmental contamination and mental disorders disproportionately affect minority populations, which is also relevant to the mission of the NIMHD.